Caring for Bebe: Early Childhood Obesity Prevention Intervention for Hispanic Families

PROJECT SUMMARY Children who are overweight during early childhood are at least 5 times more likely
than normal weight children to be overweight/obese as adults. Yet, for 2 to 5-year-olds, the obesity prevalence
is 16.7% for Hispanic children, 12.4% for non-Hispanic Black (NHB) children, 9.3% for non-Hispanic white
(NHW) children, and 9.1% for Asians. Once established, obesity and its comorbid medical conditions, many of
which disproportionally affect Hispanics, are difficult to treat and usually persist throughout adulthood. Thus,
preventing its development as early as possible in life is critical to reduce the health care costs associated with
obesity-related chronic diseases such as type 2 diabetes and cardiovascular disease. Hispanic children have a
higher prevalence of behaviors and determinants that put them at a high risk of obesity including suboptimal
breastfeeding, early introduction of solid foods, and poor infant sleep quality and duration. Current evidence
suggests that successful obesity prevention interventions occur in infancy/early childhood and are family-
based. However, few studies meet that criteria and even fewer studies target at-risk minorities. The goal of this
application is to develop and pilot the feasibility of a social media-based, bilingual, multigenerational
entertainment education (EE) intervention for primiparous Hispanic pregnant women and their mothers to
prevent the onset of obesity in infants. The aims of this study are to conduct formative research for the
development and pilot testing of an early childhood obesity preventive intervention for Hispanic pregnant
women and their mothers to establish healthy infant weight, increase breastfeeding, infant sleep, and delay
solid food introduction. In Aim 1a, qualitative data will be gathered on mother/grandmother dyads attitudes
towards content and user engagement. The results will inform the development of EE video clips and
accompanying activities. In Aim1b, we will examine mother/grandmother dyads’ acceptability of developed EE
video clips, feasibility of activities, and overall approach to dissemination. A sample of 50 Hispanic pregnant
mother-grandmother will be randomly assigned to either the experimental or control condition and followed for
6 months, with assessment at baseline (birth), 3- and 6-months. The control condition will proceed with care as
usual. This iterative process will culminate in a pilot test randomizing 50 Hispanic mother-grandmother in a 12
week intervention versus care as usual. Additionally, changes in mother and grandmother health will be
assessed as secondary outcomes and changes in social support will be examined as a potential mediators of
the effect of condition on outcomes. Covariates include sociodemographic information, health history,
measures on breastfeeding self-efficacy, and acculturation. In addition to feasibility and acceptability
measures, preliminary effect estimates will be calculated to inform a subsequent R01 trial. This proposed study
would help advance science of early childhood obesity prevention interventions by harnessing the power of
social media and EE to promote health behaviors among Hispanic families.

Public health relevance
PROJECT NARRATIVE The proposed research will develop and test the feasibility of a social-media based entertainment education intervention to prevent early childhood obesity in Hispanic infants, addressing two critical gaps in the literature: obesity prevention for children under 5 years and minority health. The intervention, Caring for Bebé, will be iteratively developed and tested with input from Hispanic mothers and grandmothers. Study results generated here will produce data and findings on three generations of Hispanic families (grandmother, mother, infant) participating in an early life obesity prevention intervention, inform the development and delivery of pregnancy and early life obesity prevention interventions, and advise actionable recommendations for pediatric and family clinical care delivered to diverse families.